Optimizing knocksideways to visualize interactions between protein subcomplexes

PROJECT SUMMARY
Genomic instability is a hallmark for cancers. More than 90% of cancer cells exhibit aneuploidy. The spindle
assembly checkpoint is a fundamental mechanism that prevents chromosomal instability by halting premature
chromosome segregation. In this project, the “knocksideways” techniques will be adapted to analyze the factors
that contribute to kinetochore localization and activity of the MAD1:MAD2 complex. Targeting the MAD1:MAD2
complex to unattached kinetochores is a crucial step to activate the spindle assembly checkpoint. Here we use
“knocksideways” in its broader meaning, which includes devising different ways to target a protein or a protein
subcomplex away from its endogenous location to a distinct subcellular niche. Such spatial isolation strategy
makes it possible to address interactions between “pre-fabricated” protein subcomplexes. If another protein
subcomplex follows suit and is diverted to the new location, this implicates positive physical interactions between
the two subcomplexes. Biochemical reconstitution and structural analysis is still the gold standard to establish
interactions between protein subcomplexes. However, the knowledge of subunits and posttranslational
modifications could be prerequisite for such reconstitution. On the other hand, traditional methods check
dependency relationship between protein subcomplexes using knockdown or knockout of one component and
analyzing the impact on other components. The dependency relationship cannot establish direct interactions nor
the sufficiency of one subcomplex in recruiting additional subcomplexes. We propose to modify and expand two
“knocksideways” schemes to analyze how the MAD1:MAD2 complex interacts with other protein subcomplexes,
either as its kinetochore receptors or as its activity regulators. In our opinion, innovative use of the
“knocksideways” analyses will help answer some key questions surrounding the MAD1:MAD2 complex. Such
techniques will also be useful in studying the building of other sophisticated molecular machineries.

Public health relevance
PROJECT NARRATIVE “Knocksideways” techniques can be adapted to understand in vivo assembly of supramolecular complexes such as kinetochores. The application of the “knocksideways” toolkits to analyze kinetochore receptors and other regulators of the MAD1:MAD2 complex is expected to provide timely information in understanding chromosomal instability and tumorigenesis.